Host-associated biofilm formation and dispersal mechanisms

Abstract
Bacteria can form multi-cellular communities in which individual cells are protected from environmental insults
such as antibiotics by virtue of being [1] encased in a protective matrix comprised of polysaccharides and other
macromolecules and [2] physiologically distinct from free-living, planktonic cells. Biofilm formation enhances
the ability of bacteria to colonize surfaces, including host tissues and abiotic surfaces such as medical implants,
and seeds subsequent infections at distal locations through dispersal processes. As a result of these
characteristics, bacteria in biofilms are responsible for the majority of hospital-acquired infections and thus
understanding how biofilms form and disperse from such biofilms is critical. Although numerous animal models
of biofilm formation have been developed, few, if any, permit visual examination of biofilm formation and
dispersal events as well as a quantitative analysis of subsequent colonization outcomes. One such robust model,
however, can be found in the Vibrio fischeri-squid (Euprymna scolopes) symbiosis. To colonize, V. fischeri first
forms a biofilm on the surface of the symbiotic organ, then disperses from it to enter and ultimately colonize sites
deep within this organ. Our work has shown that genes required for biofilm formation in laboratory culture are
similarly required for host-associated (HA) biofilms and colonization, while genetic changes that enhance
biofilm formation in the lab also strikingly enhance HA biofilms and colonization. This strong correlation affords
us an exceptional opportunity to develop and test hypotheses about the mechanisms of HA-biofilms, dispersal
and subsequent colonization. Our work has revealed that HA biofilms and colonization depend on syp, an 18-
gene locus involved in production of SYP polysaccharide, and on multiple sensor kinases and response regulators
that control syp transcription and post-transcriptional events. We have recently identified calcium (Ca2+) and
nitric oxide (NO) as a strong inducer and inhibitor, respectively, of biofilm formation. Ca2+ is a physiologically
relevant signal that appears to affect numerous processes, but how it does so is as-yet unknown. NO, which is
produced by the squid and known to influence HA-biofilms, likely impacts one of the sensor kinases required for
syp transcription, and we propose to evaluate the underlying mechanisms. We are also poised to identify other
physiological signals that promote/inhibit HA biofilms. We have recently uncovered conditions in which
dispersal can be visualized in laboratory culture, and have observed that V. fischeri undergoes multiple rounds
of formation and dispersal in fully-grown cultures, a result that suggests control by post-transcriptional
mechanisms. We have begun to investigate that process by identifying a set of genes involved in controlling
dispersal. We propose to develop a mechanistic understanding of these dispersal genes and the factors that
control dispersal events as well as to search for others that we predict to exist. We anticipate that this work will
provide insights into the mechanisms by which bacteria respond to their environment and transition in and out
of multi-cellular communities within an animal host.

Public health relevance
Project narrative Many if not most bacterial infectious diseases as well as the normal interactions between a human or animal host and its microbiome occur in the context of bacterial biofilms, communities of bacteria protected from host defenses as well as therapeutic antimicrobials. We study the symbiosis between the bacterium Vibrio fischeri and a squid as a simple animal model that permits us to readily visualize host (animal)-associated biofilm formation and dispersal, an event that permits bacteria to spread, and evaluate the underlying mechanisms. We are poised here to investigate signals and processes that promote host-associated biofilms and dispersal, and anticipate that our ability to readily investigate how bacteria enter and leave biofilms in the context of an animal will promote our ability to treat infectious biofilms in the context of human disease.